Functional Characterization of Tau Mutation and Post-translational Modifications

PROJECT SUMMARY (See instructions):
Protein aggregation is a hallmark of neurodegenerative diseases, including Alzheimer's Disease, and
these diseases lack effective therapeutics. We currently lack an understanding of the molecular and
cellular mechanisms controlling protein aggregation in the human brain, which would enable new
therapeutic strategies.
The protein tau aggregates in the brain in many neurodegenerative diseases called tauopathies, including
Alzheimer's Disease. In early stages of disease, tau aggregates only in specific neurons despite being
expressed in every neuron in the brain, implying that specific factors in the cellular environment predispose
tau to aggregation. Similarly, tau mutations are associated with the onset of only specific tauopathies.
Together, these disease features imply that tau is exquisitely sensitive to both its sequence properties and
its cellular environment.
Post-translational modifications (PTM) are a mechanism by which the cellular environment can act on a
protein primary sequence, similar to mutation. Tau is heavily post-translationally modified and changes to
tau PTMs are correlated with progression of disease. Tau phosphorylation and proteolysis are proposed to
be central events in the onset and progression of tauopathies. Similarly, mutations are correlated with early
disease onset and are known to hasten in vitro tau aggregation. Mutations can also cause changes in
PTMs by changing tau interaction partners. The function and causality of these changes to tau
aggregation, however, is unknown. I hypothesize that PTMs and mutations license tau to access specific
conformations to form aggregates.
The goal of this proposal is to comprehensively identify (1) the biological basis of tau PTM changes and
(2) how tau mutation and PTMs cause aggregation. I have shown that mitochondrial electron transport
chain dysfunction causes remodeling of tau PTMs, including the accumulation of a tau proteolytic
fragment. In Aim 1, I will acquire new training in mass spectrometry (MS)-based proteomics to determine
the tau PTM changes that occur due to ETC dysfunction and how those control tau aggregation. In Aim 2, I
will use deep mutational scanning (OMS) to comprehensively probe tau's sequence-structure relationship.
As part of Aim 2, I will use cross-link MS to directly compare in vitro and in vivo tau states to reveal the
structural mechanisms for the identified PTM and sequence changes. I am ideally positioned to complete

Public health relevance
RELEVANCE (See instructions): Aggregation of the protein tau is thought to drive several neurodegenerative diseases, including Alzheimer's Disease, that lack disease-modifying therapeutics. The goal of this proposal is to gain a comprehensive understanding of how the misfolding and aggregation of tau is controlled by the combination of its sequence and its cellular environment in human neurons. Completion of this proposal has the potential to provide unique insight into fundamental properties of protein misfolding in the brain and